Elucidating the signaling pathways that underlie calcium-dependent myelin remodeling

PROJECT SUMMARY/ABSTRACT
Myelin is crucial for efficient neural communication and proper circuit function. Recent evidence shows that
myelin is not static but capable of remodeling throughout life, influencing learning, memory, and behavioral
adaptation. Calcium signaling is a well-established driver of myelin formation during development, yet the
mechanisms underlying activity-dependent calcium signaling in mature myelin and its role in myelin remodeling
remain poorly understood. The mechanisms linking neuronal activity to calcium dynamics in myelin sheaths and
their structural changes during learning are unexplored. This project will test the hypothesis that learning-induced
neuronal activity drives intracellular calcium release through inositol triphosphate receptors (IP3Rs) in myelin,
triggering structural remodeling. Aim 1 will use in vivo 2-photon imaging in awake, behaving mice to determine
how neuronal activity induces calcium signals in pre-existing myelin and whether these signals predict
remodeling. Aim 2 will combine genetic and pharmacological tools to test whether IP3R-mediated calcium
release is essential for myelin retraction and motor learning. Results from these studies will elucidate the
molecular pathways that mediate activity-dependent myelin remodeling, providing critical insights into how
myelin plasticity contributes to neural circuit function. This work has significant implications for understanding the
pathophysiology of myelin-related diseases, such as multiple sclerosis, and could uncover novel therapeutic
targets for enhancing CNS plasticity and repair.

Public health relevance
PROJECT NARRATIVE Myelin, produced by oligodendrocytes, is essential for fast and efficient neuronal communication, and recent evidence demonstrates that mature myelin is dynamic, playing a role in learning, memory, and neurological diseases. This project investigates the hypothesis that neuronal activity induces calcium transients in myelin sheaths via inositol triphosphate receptor (IP3R)-mediated intracellular calcium release, driving structural changes to myelin. Employing cutting-edge imaging techniques, behavioral assays, and genetic tools, this proposal aims to generate insights that will transform our understanding of myelin loss in demyelinating diseases, such as multiple sclerosis, and myelin plasticity deficits associated with various neuropsychiatric and neurodegenerative disorders.